Senior Leadership

Senior Leadership at the UT Southwestern Simmons Cancer Center is comprised of the Director, Deputy Director, three Associate Directors representing basic, clinical and population research and the Associate Director for Administration. These leaders are responsible for collaborations across the scientific programs of the Center, direction and strategic planning, oversight of shared resources, education, and development of community outreach and budgetary oversight. Over the past four years. Dr. James Willson has provided vision and strong leadership as Director of UT Southwestern Simmons Cancer Center. Dr. Joan Schiller was appointed Deputy Director in 2006 and has led the development of the Center's disease oriented teams and an enabling clinical research infrastructure that has been integrated with the Medical Center's affiliated hospitals. Dr. Michael White serves as Associate Director for Basic Research and in this role has been instrumental in the development of the Center's basic research programs and the engagement of UT Southwestern cancer researchers into the Cancer Center. Dr. David Euhus serves as Associate Director for Clinical Research and in this role he is responsible for developing and maintaining a robust clinical trials enterprise for the Cancer Center and in partnership with the Deputy Director has responsibility for the oversight of the clinical trials support resources and the protocol review and monitoring system. Dr. Celette Sugg Skinner, who joined the Simmons Cancer Center in 2007, serves as Associate Director for Population Science. In this role she is leading the development of a research program in population science and cancer control and building interactions between basic and clinical faculty across the cancer control spectrum. This leadership team functions as a cohesive group that together has catalyzed new transdisciplinary collaborations and coordination that are transforming the cancer research environment at UT Southwestern.